INTEGRATING PHARMACY-BASED PREVENTION&TREATMENT OF OPIOID&OTHER SUBSTANCE USE DISORDERS: A SURVEY OF PHARMACISTS&STAKEHOLDERS. 9/1/2020-7/31/2022. N01

Integrating pharmacy-based prevention and treatment of opioid and other substance use disorders: A survey of pharmacists and stakeholder (CTN-0105)